Examining the role of the miR-181a:Wnt/B-catenin axis in ovarian cancer

Project Summary/Abstract
High grade serous carcinoma (HGSC) the most common type of “ovarian” cancer is one of the deadliest
cancers diagnosed in women. One of the primary drivers for the high mortality rate associated with
HGSC is tumor recurrence and chemoresistance. Thus, there is a critical need to identify the genetic
drivers of tumor development and recurrence to improve therapeutic strategies. In this proposal, we
provide extensive evidence for the clinical and biological importance of miR181a, which is amplified in
a large majority of HGSC patients, correlates with poor overall survival, and induces epithelial to
mesenchymal transition (EMT), metastasis, drug resistance, and stem-like cell properties. Remarkably,
this correlation between miR181a with clinical outcome and recurrence has also been shown in
numerous other cancers. Notably, miR181a expression in HGSC tumors offered stronger prognostic
value than established clinical biomarkers. Furthermore, analysis of >10,000 tumors representing 20
different cancers revealed that amplification of miR181a correlated with poor outcome. Most recently,
we have uncovered a novel mechanism through which miR181a can drive tumor development at the
earliest stage through the cooperative targeting of RB1 and Stimulator of Interferon Genes (STING).
Enhanced miR181a promoted the growth of highly aggressive and genomically instable cells through
the direct inhibition of STING, a key activator of interferon signaling in response to cytoplasmic DNA.
Though activating anti-tumor immunity is increasingly being recognized as an important therapy in
cancer treatment the efficacy of current immunotherapies for the treatment of HGSC has not been
successful mainly due to the highly immunosuppressive microenvironment. One of the primary means
by which a tumor creates an immunosuppressive microenvironment is by inhibiting STING signaling
within the tumor. Thus, our novel finding showing that miR-181a directly regulates STING introduced
unique opportunity to assess whether therapeutic targeting of the miR-181a will reactivate IFN signaling
via STING to overcome immune tolerance that is commonly seen in HGSC tumors. We will interrogate
the cooperativity between miR181a and STING through the following aims: 1) Determine the effect of
miR181a loss on immune cell infiltration and IFN signaling using patient-derived organoids in the
presence and absence of either a STING agonist or anti-PDL1, 2) Ascertain the role of miR181a on
the sensitivity to STING agonist or anti-PDL1 in vivo, 3) Assess whether miR181a activation is sufficient
to drive tumor formation alone or in combination various combinations of tumor suppressor genes in
mice. Through these complementary studies, the goal is to characterize the mechanism by which
miR181a regulation of STING can re-engage the cytotoxic anti-viral signaling machinery in HGSC and
assess how miR181a is promoting tumor development.

Public health relevance
PROJECT NARRATIVE The goal of the proposed research is to interrogate the role of miR-181a in the emergence of immune tolerance and tumor development through the regulation of Stimulator of Interferon Genes (STING). Defective STING signaling is one of the primary means by which a high grade serous cancer (HGSC) create an immunosuppressive microenvironment thus its re-activation can potentially induce tumor interferon signaling, decrease tumor volume, as well as induce anti-tumor innate/adaptive immune response. We propose to test the co-operativity between miR-181a loss and STING agonists to restore innate immune signaling in HGSC and induce tumor cell death and ultimately have a significant impact on public health.